Cancer Center Support Grant

Director’s Overview and Six Essential Characteristics
ABSTRACT
The City of Hope Comprehensive Cancer Center (COHCCC) brings together 135 Members from 23 Departments
in the City of Hope National Medical Center and the Beckman Research Institute of City of Hope. The Center
receives $16,688,443 (Direct) in peer-reviewed funding from the NCI, $15,062,557 (Direct) from other peer-
reviewed sources, and $31,637,093 from non-peer-reviewed sources, for a total of $63,388,093 (Direct) in overall
funding. Through faculty recruitment, reorganization, and significant infrastructure development, the COHCCC
has greatly enhanced its ability to accelerate clinical and translational cancer-focused research. Fifty-three new
faculty have been recruited during the most recent funding period, including 31 clinical investigators, and 23
basic and population research scientists. The Cancer Center has five Programs: Molecular and Cellular Biology
of Cancer (MCBC), Developmental Cancer Therapeutics (DCT), Cancer Immunotherapeutics (CI), Hematologic
Malignancies (HM), and Cancer Control and Population Sciences (CCPS). In addition, the COHCCC supports
nine Shared Resources: Analytical Cytometry, Analytical Pharmacology, Integrative Genomics & Bioinformatics,
Multi-omics Mass Spectrometry & Biomarker Discovery, Pathology Research Services, Small Animal Studies,
Drug Discovery & Structural Biology, Biostatistics & Mathematical Oncology, and GMP Manufacturing.
Significant infrastructure and other resources have been created to facilitate the translation of discoveries to the
rapid development of new cancer treatments, diagnostic tests, and other interventions that will aid people with
cancer, as well as individuals at risk for malignancy. Our research is aligned to reduce the incidence of cancer
in the unique populations we serve within our Catchment Area, through investigating 1) biologically aggressive
cancers that impact diverse populations; 2) viral-related cancers, including hepatocellular carcinoma and HPV
and HIV-related malignancies; 3) the impact of pollution on cancer incidence, with a focus on breast and lung
cancers; and 4) cancers of aging in Asian- and Latino-Americans. In addition, the COHCCC is committed to
developing the next generation of leaders and practitioners in clinical and translational cancer-related research
through robust training initiatives that begin at K-12 outreach and continue through junior faculty development.
Finally, overall organization of the institution and its administrative capabilities in terms of leadership,
programmatic alignment, development, and authority have been augmented so that the Cancer Center will be
more responsive to its members and to harness their collective energies and creativity. This application
documents that the COHCCC has addressed all of the concerns in the prior review, and that Leadership has
built a solid structure for achieving its missions and a stronger more sustainable institution than it has ever been.

Public health relevance
Narrative The City of Hope Comprehensive Cancer Center provides critical infrastructure and shared resources and fosters collaborations among our basic, population, and clinical investigators to identify new methods for the prevention, diagnosis, treatment, and rehabilitation of cancer.